Reducing the CNS reservoir through myeloid cell depletion

PROJECT SUMMARY/ABSTRACT
HIV infection results in CNS comorbidities, with nearly 75% of patients with advanced HIV disease showing
neurological manifestations. The blood-brain barrier prevents antiretroviral drugs from entering the CNS, and
thus a reservoir occurs. Macrophage and microglia remain at least latently infected, awaiting an insult to
reawaken. A recently FDA-approved drug, Pexidartinib, has been used to safely deplete microglia and
macrophages. These microglia are believed to repopulate from the subventricular zone, with initial cells being
CD4-ve. This could render these cells impervious to infection. Further, SIV infection makes macrophages
resistant to apoptosis: Pexidartinib restores this apoptotic sensitivity. This could provide an avenue to examining
the depletion of latently infected cells from the CNS, with the potential for diminishing later neurological disorders,
including the major CNS comorbidity: HAND.
There is debate that latently-infected microglia and macrophages can be a source of viral rebound to the
periphery. Removing those microglia after viral setpoint, with macaques on stable cART, and determining if the
CNS reservoir can return, could answer this very question. The effects of transiently depleting microglia from the
CNS, especially in the context of SIV infection, represent a significant gap in our knowledge. Therefore, there is
a critical need to understand the effects of transiently removing latently-infected microglia from the CNS in SIV
neuropathology. This R21 application seeks to address how removing microglia from the CNS influences
neuroinflammation both positively and negatively in the context of SIV infection.

Public health relevance
PROJECT NARRATIVE HIV infection results in CNS complications, with nearly 75% of patients with advanced HIV disease showing neurological manifestations. Macrophages and microglia are key cells to maintaining a CNS reservoir for SIV. This application seeks to understand mechanisms whereby the reservoir can be depleted in the context of SIV infection of macaques on cART.